Neuronal PARP activity in fetal alcohol spectrum disorders

Fetal alcohol spectrum disorders (FASD) are the leading known and preventable causes of intellectual disability. They impair executive functions including working memory, a function highly dependent on the medial prefrontal cortex (mPFC). This brain region is one of the last to mature, the third trimester in humans and the first 10 days after birth in rats. This is a vulnerable period for mPFC dendrites where their growth is prone to disruption from environmental insults, such as ethanol (EtOH). Poly ADP ribose polymerases (PARP) proteins are implicated in several cellular functions, including regulating gene expression. PARP synthesizes and attaches poly (ADP-ribose) (PAR) chains (PARylating) to its targets. PARP enzymes can affect gene expression by PARylating the epigenetic enzyme KDM4D. This reduces KDM4D’s ability to remove the transcriptionally repressive, dimethylated lysine 9 at histone H3 (H3K9me2). PARP-mediated gene silencing can also be accomplished by PARylating the transcription factor Peroxisome proliferator-activated receptor gamma (PPARγ). Our underlying hypothesis is that EtOH induces PARP1 activity, promoting the addition of PAR groups to known PARP1 targets such as PPARγ and KDM4D. This post-translational modification would then reduce PPARγ and KDM4D’s ability to bind DNA or chromatin resulting in changes to neurodevelopmental gene expression, dendritic arborization, and working memory. This hypothesis is supported by our preliminary data in which EtOH increased PARP activity and reduced Bdnf IV, IXa, and Klf4 mRNA expression in primary cortical neuron cultures. These changes were reversible with a PARP inhibitor. As a direct connection between PARP and PPARγ we found that PARP inhibition increased PPARγ binding to Bdnf IV and Klf4 promoters in vitro. In vivo, neonatal EtOH treatment induced PARP activity, and this coincided with a decrease in PPARγ DNA binding ability and reduced Bdnf IV mRNA expression. Thirty-one days after the final dose, the reduction in Bdnf IV expression persisted in EtOH exposed rats. In the first aim, we plan to dissect the molecular mechanisms connecting PARP to changes in developmental gene expression in the mPFC with a focus on neuron-specific changes. In order to establish the role of PARP in EtOH induced Bdnf and Klf4 gene expression silencing we will attempt to prevent expression changes by administering a PARP inhibitor ABT-888 to EtOH treated rats. We will also dissect whether PARP mediated transcriptional repression occurs via post-translational modifications to PPARγ and KDM4D using neuron cultures. In the second aim, we will establish the role of PARP in the much-replicated deficits in mPFC dendritic arborization and neuritogenesis observed in FASD models. In the third aim, we will study the role of PARP in third trimester equivalent EtOH exposure-induced spatial working memory deficits. PARP inhibitors are known to be neuroprotective, are currently undergoing clinical trials for other disorders, and cross the blood-brain barrier. Therefore, the results of these studies may be a promising avenue for future pharmacological development.

Public health relevance
Fetal alcohol spectrum disorders (FASD) are the leading identifiable and preventable cause of intellectual disability. This project is highly innovative in that it examines how a key enzyme in gene regulation, Poly ADP Ribose Polymerase (PARP), known to be altered by ethanol exposure, produces the profound and lifelong neuropsychiatric manifestations of FASD. This study has important clinical implications as there are currently FDA-approved drugs that target this pathway that may be able to reverse the underlying developmental gene expression abnormalities caused by fetal alcohol exposure.